Molecularly Engineered Biomaterials for Minimally Invasive Dental Treatment

DESCRIPTION (provided by applicant): Molecularly Engineered Biomaterials for Minimally Invasive Dental Treatment Molecularly-engineered biomaterials are an ideal candidate for minimally invasive dental preparations, caries removal, and other dental treatments, including cleaning in perigingival zone and other general cleaning and whitening. Through the control of molecular structure, the biochemical and biomechanical properties can be tailored and optimized. The investigators propose to use the well- established biochemistry to create a class of new dental materials useful for minimally-invasive dental preparation and useful as tissue repair agents potentially loaded with therapeutics. Processing chemistry is to be integrated with advanced nano/micro-fabrication technology to enhance the success rate of the Phase I feasibility. Preliminary toxicity assessment will also be conducted on selected materials. Phase II will focus on the biomechanical performance in vivo, especially regarding dental preparation and defect removal.

Public health relevance
Molecularly Engineered Biomaterials for Minimally Invasive Dental Treatment Molecularly engineered biomaterials as new classes of dental materials have the potential for minimally invasive removal of decayed tooth, composites, resin, orthodontic resin, pit & fissure resin, ceramic bracket cement and temporary cement. They also have the potential of improving the quality of dental cleaning and whitening while shorting the time and reducing the overall cost. Dental defects removal using molecularly engineered biomaterials may also promote new bone-like mineral formation. The likelihood of a successful completion is enhanced when well-established biochemistry and processing chemistry are integrated with advanced nano/micro-fabrication technology for the creation of new generation of dental materials with tailored bioactivities and biomechanical properties.